Advancing Neuroscience Research by Modernizing Animal Housing to Improve Animal Well-Being and Science

Project Abstract
The University of Chicago has a robust and growing neuroscience program. Central to these research studies
are non-human primates trained to perform behavioral tasks as part of the research. Training of these behavioral
tasks takes months to years to complete and successful outcomes require animals to be in their best physical
and psychological health. Assuring animals are kept in excellent health is a shared mission of the Animal
Resources Center and the neuroscience laboratories. We approach animal care collaboratively to look for ways
to improve animal welfare and research outcomes. This strategy has allowed the Animal Resources Center to
make numerous improvements in the care and use of animals at the institution. We propose to outfit newly
renovated rooms with a new multi-animal housing system which will increase the size and quality of space
available to the animals, enhance their ability to express species-typical behaviors in an enriched environment
and improve their social housing opportunities. With these new enclosures, we will be better able to approximate
a natural environment for the animals, which in turn makes them better suited for research of human conditions
and contributes to enhanced reproducibility and the integrity of the science. We anticipate with this positive
change, health problems will potentially be decreased due to improvement in enrichment opportunities and social
housing. These enclosures also will streamline operations by creating larger social groups with abundant
enrichment space, which will eliminate the need to move enrichment play cages between rooms, and will
eliminate the need to move and transport cages between animal rooms and cage wash. This will decrease labor
associated with cage changing and cage washing. An environmental impact, through the reduced use of cage
wash water, steam, and electricity is also expected. The new housing system will also increase our capacity for
maintaining additional primates in the same room by allowing more animals to be housed in the enclosures than
possible with standard caging systems. The most enthusiastic aspect of this proposal, however, is the ability to
initiate cage side research studies within these enclosures. Cage side studies allow the monkey to conduct their
work in their home cage voluntarily without the need for transport to the laboratory, thus also eliminating the
need for techniques for water access scheduling in some animals. This will streamline research operations in
addition to the husbandry efficiencies already mentioned. The transition to a new housing system will, therefore,
not only provide an environment that promotes improved animal health and psychological well-being, and
streamline husbandry operations, but will also positively impact research outcomes and improve scientific
operations by pioneering a new method to collect research data with the animals.

Public health relevance
Project Narrative This proposal seeks to purchase and install a new housing system to modernize the environment in which non- human primates for neuroscience research live. The new housing system will increase the size and quality of space available to the animals, enhance their ability to express species typical behaviors in a more enriched environment and improve their social housing opportunities. The new housing paradigm will benefit the overall well-being of the animals, streamline operations of the animal facility and by extension will improve research outcomes of the studies.